Translational quality control by trans-editing domains

Summary
Aminoacyl-tRNA synthetases (ARSs) establish the rules of the genetic code, whereby each
amino acid is attached to a cognate tRNA. Errors in this process lead to mistranslation, which
can be toxic to cells. Approximately half of the ARSs possess a proofreading (or editing)
function to hydrolyze mischarged aa-tRNAs and evidence that non-proteinaceous amino acids
pose the greatest threat to fidelity is beginning to emerge. Early work in the Musier-Forsyth lab
focused on our discovery of Class II prolyl-tRNA synthetase (ProRS) editing. This led to a
mechanistic understanding of the bacterial ProRS posttransfer editing domain (INS) and the
demonstration that the INS domain. We subsequently discovered that single-domain INS
homologs are widespread in Bacteria and in recent years, our focus in this area has turned
almost entirely to understanding the function of these INS-like domains in tRNA editing.
However, many open questions regarding the physiological function of these putative trans-
editing proteins remain. The overarching goal of the research described in this MIRA application
is to uncover the specific functions of a growing family of trans-editing proteins known as the
INS superfamily. This diverse yet universally conserved family now has a solid and
accumulating in vitro structure-function knowledge base, which strongly supports a role in
maintaining translational fidelity. Our knowledge of the broader physiological roles of these
proteins, especially in eukaryotes, is still in its infancy and is just beginning to reveal wider roles
than previously anticipated. This major gap will be addressed in this work.

Public health relevance
Project Narrative This MIRA application seeks to uncover the specific functions of a growing family of trans- editing proteins that play a universal role in maintaining the fidelity of protein synthesis. Our knowledge of the broader physiological functions of these proteins, especially in eukaryotes, will be addressed in this work. The therapeutic potential of trans-editing domains has not been exploited and represents another major gap in the field that we hope to address by our planned studies.